Mannosidase-stabilized glycan immunogens for elicitation of high mannose patch antibodies

Project Summary/Abstract
HIV broadly neutralizing antibodies (bnAbs) most commonly target the High Mannose Patch (HMP), a
mannose-rich region of HIV Env in the vicinity of the V3 loop and the N332 glycan. HMP bnAbs (e.g.,
2G12, PGT128, BG18) tend to recognize non-reducing-terminal Man1α-2Man moieties within
oligomannose glycans; however, in immunizations with oligomannose glycoconjugates, antibodies are
rarely raised against Man1a-2Man, and instead bind to core motifs of the glycan. We hypothesize that in
vivo mannosidase trimming of Man1a-2Man termini is a major reason why antibodies do not develop
against this motif. In Aim 1, we will prepare stabilized oligomannose glycans, in which a sulfur linkage
prevents mannosidase cleavage of the Man1α-2Man, but structurally mimics the natural glycan and is
recognized by bnAbs. In Aim 2, we will immunize rabbits with CRM197 glycoconjugates containing the
stabilized or unstabilized glycans and compare the resulting antibodies’ HIV Env binding and
neutralization activity. We will also intensively characterize the ability of these antibodies to bind Man1a-
2Man using an oligomannose-focused glycan array.

Public health relevance
Project Narrative The protein on the surface of the HIV virus is coated with a dense network of carbohydrates. Some of the best antibodies generated in natural HIV infection bind to these carbohydrates, but such antibodies normally arise too late to eliminate the infection, if they arise at all. This project will develop synthetic, stabilized variants of these carbohydrates, which will be tested as vaccines to stimulate carbohydrate- binding antibodies that may protect against HIV.